Error-enhanced Learning & Recovery in 2 & 3 Dimensions

ABSTRACT
Treating post-stroke individuals with physical devices (mechanoceuticals) has produced mild but significant
recovery. While clinicians widely recognize that therapy should focus on movement error, there is currently no
“model” of relearning that can inform the design of treatments. We will develop an individualized mathematical
model of each person’s unique response to error that can serve both as a descriptor and a hypothesis for testing
the practice environment to correct the individual’s deficits. Our aims will model and test therapy that focuses on
(1) central tendencies of error, (2) sensory contributions to error, and (3) variations of error. Our anticipated
findings will not only shed light on how to improve therapy, it will test hypotheses about the fundamental
processes of practice and learning. This work will move us closer to our long-term goal of knowing the most
effective treatments, using either therapists or devices.

Public health relevance
NARRATIVE There are a variety of motor deficits following stroke which present growing challenges to healthcare. Therapeutic practice with physical devices remains an exciting frontier for the recovery of function, but a critical question is precisely how such devices should be programmed. Here we investigate differences in outcomes using models that describe how a person responds to error during practice, and we evaluate how well these models can prescribe the best therapeutic training.